EFFICACY OF ORAL CISAPRIDE IN CHILDREN WITH CHRONIC INTESTINAL PSEUDOOBSTRUCTION

To evaluate the efficacy of cisapride in the treatment of pseudo- obstruction in children. Signs and symptoms of pseudo-obstruction will be compared in cisapride or placebo treated groups.